Role of Creatine Metabolism in Necrotizing Enterocolitis

PROJECT SUMMARY
Necrotizing enterocolitis (NEC) is an inflammatory gastrointestinal disease of the neonatal period with an unclear,
and likely multifactorial, pathogenesis. NEC most often affects preterm, very low birthweight (VLBW, < 1500 g)
infants, and risk factors including dysbiosis, formula feeding, and prematurity have been implicated in NEC
etiology. Our long-term goal is to identify nutritional strategies promoting postnatal intestinal resilience to
environmental, developmental, and microbiological influences increasing susceptibility to NEC. Creatine (Cr) is
an amino acid derivative with demonstrated antioxidant, anti-inflammatory, and bioenergetic benefits in a number
of diverse diseases. During inflammatory bowel disease (IBD), reduced Cr production or uptake promotes
intestinal epithelial cell (IEC) dysfunction, while Cr supplementation stabilizes intestinal barrier function, improves
bioenergetics, and accelerates wound healing. While fetal Cr is provided through maternal transfer, infants must
endogenously synthesize Cr postnatally, as both human milk and infant formula contain negligible levels. In
preterm infants, a lack of third trimester accretion of the nutrient due to premature birth, immature functionality
of enzyme systems responsible for endogenous synthesis, and increased requirements due to rapid growth and
development in the neonatal period likely render Cr a conditionally essential nutrient, and one in which these
infants are likely deficient at homeostasis. Periods of intermittent hypoxia, a common maturational consequence
of prematurity, and the development of acute intestinal inflammation could further extend the requirement for Cr
in this population. Our preliminary data suggest Cr accelerates intestinal epithelial restitution following wounding
and inhibits caspase 3/7-induced apoptosis in a preterm human intestinal enteroid model of NEC-like
inflammatory injury. This project will test the hypotheses that (Aim 1) Cr deficiency detrimentally affects preterm
infant intestinal epithelial injury, while Cr supplementation prevents NEC-like injury, and that (Aim 2) Cr
metabolism is bidirectionally related to NEC development in preterm infants, with low urine Cr levels in preterm
infants a proxy for systemically low Cr stores and/or high tissue Cr utilization, and intestinal Cr depletion
associating with development of NEC. Successful completion of this project will introduce a novel treatment
target for NEC, a condition for which there are currently no effective prophylactic alternatives to human milk, and
no effective therapeutics beyond surgical intervention and supportive care, using a supplement already noted to
be well-tolerated in the preterm population.

Public health relevance
PROJECT NARRATIVE Necrotizing enterocolitis (NEC), a gastrointestinal emergency in premature infants, has no effective treatments beyond human milk feeding. The current proposal seeks to explore a potential risk factor for NEC development, low levels of the natural product, creatine, as well as investigate the ability of creatine supplementation to prevent NEC-like injury in cell-based models of the disease.